SURVEILLANCE, EPIDEMIOLOGY, AND END RESULTS (SEER) - PEDIATRIC CANCER WHOLE SLIDE IMAGING

Project Abstract: Creating and storing images of microscopic slides generated during cancer diagnoses and surgical treatment provides an opportunity to allow for research use of histopathological information and extracted microscopic features to better understand disease outcome and response to treatments. The Surveillance Research Program (SRP) at the National Cancer Institute (NCI), which funds and operates the Surveillance, Epidemiology, and End Results (SEER) cancer registry system, is conducting the Pediatric Cancer Whole Slide Imaging Pilot (Pilot) to establish the feasibility of, logistical and technical pipelines for, and best practices for obtaining whole slide images (WSI) from pediatric cancer cases.